Assembly and regulation of dynamic PKA macromolecular signaling systems

DESCRIPTION (provided by applicant): cAMP-dependent protein kinase (PKA), ubiquitous in mammalian cells, regulates a plethora of cell processes including development, differentiation, memory, and metabolism and is associated with many diseases including multiple endocrine disorders and cancer. It serves as a prototype for the protein kinase superfamily and its activation by cAMP is a classic example of allosteric regulation. While our studies of PKA structure and function have given us a molecular understanding of individual PKA catalytic and regulatory subunits, over the past four years we have added a new dimension to our understanding of PKA signaling by solving structures of PKA tetrameric holoenzymes. These first glimpses of the full-length proteins force us to appreciate that PKA functions as a complex and multicomponent signaling system. Protein kinases have evolved to be dynamic and highly regulated molecular switches, not efficient catalysts, and we simply cannot appreciate or understand how this PKA signaling system works and how it is allosterically regulated by cAMP without seeing the full-length holoenzymes. It is these large multi-domain tetrameric complexes that represent the physiological state of PKA signaling in cells, and the quaternary structure of each isoform (RIα, RIβ, RIIα, and RIIβ) is different, as we had predicted based on our low resolution SAXS analyses. Our goals now are to further define the molecular features of these holoenzymes as integrated and finely tuned systems using RIα and RIIβ holoenzymes as prototypical isoforms that nucleate dynamic multicomponent macromolecular PKA signaling complexes. Aim I focuses on RIα and uses a disease mutation of RIα to dissect the pathway for allosteric signaling from one cAMP-binding domain to the other. Crystal structures of the full-length mutant holoenzyme will be validated using solution methods such as SAXS and SANS while mutagenesis will confirm interfaces and provide functional, mechanistic insights. To build higher levels of RIα complexity we focus on two newly discovered proteins. P-Rex1, up-regulated in cancers, is a guanine nucleotide exchange factor for Rac1 that binds through its two PDZ domains to the C-terminal PDZ motif of RIα. To the N-terminal D/D domain we are adding a small newly discovered membrane associated RI-specific AKAP, smAKAP. In Aim II we are building a quantitative model for PKA signaling by RIIβ. We specifically define the role of phosphatases, metals (both Mg2+ and Ca2+), and phosphodiesterases. We introduce new concepts by showing the importance of the turnover of a single phosphate in RIIβ and emphasize that the release of cAMP from RIIβ is not diffusion limited. Finally, in Aim III we build higher levels of complexity for the RIIβ signalosome by adding a dual-specific AKAP, DAKAP2, to the holoenzyme. DAKAP2 is a multi-domain AKAP that regulates recycling by binding through its PDZ motif to PDZ-K1, which links it to transporters, and through its RGS domains that bind to Rabs. In parallel with crystallography, we will use small angle Xray and neutron scattering as well as single particle image reconstruction to monitor conformational changes and domain organization in solution.

Public health relevance
PUBLIC HEALTH RELEVANCE: Cyclic AMP-dependent protein kinase (PKA), ubiquitous in mammalian cells and associated with many diseases, including cancers, is assembled as a macromolecular complex at specific sites in the cell where it regulates functions such as memory, cell migration, differentiation, and metabolism. Here we are defining the molecular and dynamic features of this signaling system that is nucleated in an isoform specific way by the regulatory and catalytic subunits of PKA at high resolution by crystallography and at low resolution using solution methods that include small angle X-ray and neutron scattering and single particle EM imaging. A final goal is to create a quantitative model of the PKA signaling system.